Understanding the Impact of Post-Separation Abuse on Children's Health and Flourishing Outcomes

PROPOSAL SUMMARY
Maternal survivors of IPV and their children often face ongoing abuse and harassment, safety concerns, lack of
financial resources, and legal constraints around custody following separation from an abusive partner that
may impact children’s health, school engagement, and flourishing and impede their children’s access to health
care. The purpose of this exploratory mixed-methods study is to develop knowledge of post-separation abuse
and examine how post-separation abuse predicts pediatric health and flourishing outcomes. The specific aims
are: 1) Understand post-separation experiences of maternal IPV survivors including post-separation abuse,
their children’s health and flourishing, and the structural context of family court, 2) Examine if the prevalence of
children’s special health care needs, unmet health needs, school engagement, and flourishing differs for
children exposed to post-separation abuse as compared to US children overall, 3a) Test construct validity and
reliability of new items developed from the qualitative phase as measures of post-separation abuse, 3b)
Determine if post-separation abuse predicts children’s health and flourishing outcomes. The study will begin
with a qualitative arm using iterative thematic inquiry to explore maternal survivors experiences of post-
separation abuse and their children’s health (n=30). The qualitative arm will also identify new items of post-
separation abuse not captured by existing measures of coercive control (WEB) and the risk of lethality (DA) to
create a new scale (Maternal Child Experiences of Post-Separation Abuse, or “MCEPSA” Scale) that will be
tested in the exploratory quantitative arm. In the second quantitative phase, cross-sectional surveys will be
administered to mothers (n=150) to assess their children’s (age 6-17) unmet health needs, special health care
needs, school engagement, and flourishing utilizing items from the NSCH, and then compare prevalence rates
of children in our recruited sample to national prevalence data from the NSCH using test of proportions. In
addition, we will conduct preliminary psychometric testing of the new items from the qualitative arm. Further,
the study will use logistic regression to examine which measure (WEB, DA, MCEPSA) of post separation
abuse best predicts children’s unmet health needs and special health care needs and to determine if the new
items in the MCEPSA are significant above and beyond the WEB and DA in predicting children’s special health
care needs and unmet health needs. Finally, the results of the quantitative and qualitative phases will be
integrated, and the quantitative data will be presented along with themes and quotes from the qualitative data.
This mixed-methods study will document health disparities and provide foundational knowledge for nursing,
policy makers, public health professionals, and judicial decision-makers to understand how post-separation
abuse and the structural context including family court processes combine in complex ways to affect children’s
health and flourishing. The study will identify potential areas of intervention in order to develop differential
systems responses to promote positive health for children exposed to post-separation abuse.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it addresses an important gap in understanding relational health risks that affect child health and development. The purpose of this exploratory mixed-methods study is to develop knowledge of post-separation abuse and examine how post-separation abuse impacts children’s health needs and flourishing outcomes. This research is relevant to NICHD’s priority to understand the developmental impact of adverse childhood experiences, identify opportunities for intervention, and ensure that all children have the chance to live healthy, safe, and productive lives.